Preparative binary pump HPLC system with UV and refractive index detector capabilities

Our NIH-funded project (1 R15GM152969-01) focuses on synthesizing and characterizing
fluorescent probes operating in the red to near-infrared region to measure pH levels within
organelles. The current synthesis involves multiple steps, with silica gel chromatography causing
delays and inefficiencies. The proposal suggests acquiring a preparative high-pressure liquid
chromatography (HPLC) system to improve purification at each step, addressing the limitations
of traditional silica gel column chromatography. The decision is driven by the complexity of the
probes and the need for enhanced resolution in separating closely related compounds. The shift
to preparative HPLC is expected to streamline the synthesis process and improve the overall
efficiency of the project.

Public health relevance
Research Strategy Our NIH award 1 R15GM152969-01 entails the synthesis and characterization of fluorescent-based probes operating in the red to near-infrared region to determine pH levels within organelles. It is critical to produce probes that would function ratiometrically as that would negate erroneous measurements based on differential diffusion rates. The syntheses of these probes involve many steps and at the end of each stage, as the compounds cannot be separated based on solubility differences, silica gel chromatography is employed. This requirement ends up adding days to the synthesis. Chromatography requires lots of glassware to do the synthesis and collect all the various fractions, not to mention the huge quantities of solvents such as dichloromethane that are utilized in these steps. Great skill is also required to prepare the columns and, while this is quite constructive, some preps are not as good as others and, in some cases, effective separation of the compounds is not accomplished. Unfortunately, we do not possess such a system in our laboratories. Our synthesis schemes are very involved,1-23 and we are going to use this equipment to purify compounds at every step of the process. We propose acquiring a preparative high-pressure liquid chromatography (HPLC) system for the purification of our reaction products, moving away from the conventional approach involving silica gel packed columns. This shift is driven by the superior capabilities of preparative HPLC, which excels in achieving enhanced resolution and improved separation of closely related compounds. Our decision is grounded in the intricate nature of our probes, composed of multiple fluorophore components linked through complex, multi-step synthetic procedures, where traditional packed silica gel column chromatography used in organic labs is often incapable of effectively separating side products with subtle structural variations. An example of one synthetic pathway is shown below. OO ,O O HO Pd(PPh3)4 HO N Toluene, water O DCC, DMAP HN Toluene, acetic acid, isopropylamine I O H O Dean Star apparatus 26 OH 100 oC, 8-h OH CH2Cl2 OH reflux OH O H HOOC O CH3SO3H N O N O H2N R1O R1 100 oC, 5 h (HO)2B OH N O R1O N COOH I 29 O 30 25 27 28 OH 31 OOH OR1 or group BN OR1 R1 , sodium ascorbate, THPTA 32 FF N OR1 33 N CuSO4 FB OR1 O H O FN O R1 HN R1 HN N3 O O NH OS NH2 R HN O O O O 8O OH OH 36a OH R HN OR1 OR1 OR O N3 O N OH OR1 OR1 O 8 HN O OR OR HN O HN O O N 36b N F B N FNB N FFB N HN O OR OH F OH F O OH N 35 N3 O O NH S Probe A1 OH FFB N 34 36c O SO3 N3 N Probe A2 R1O OR1 N or RO OR R1 O P N3 O 8 36e N R Where 36d N N N N SO3 NN NN NN N O P R group N O O N O N N O O Br N N O NH S NH2 O O NH S 8 8 8O O O 8 O amphiphilic zwitterion moiety Goblegni zaepnpeasrautlufosn-sapmeicdiefic Lysomsoormpeh-oslpineecific Mitochondria-specific Cell membrane-specific ER-specific p-toluenesulfonamide triphenylphophonium bromide Preparative HPLC provides the advantage of employing different stationary phases and fine-tuning mobile phase conditions, allowing targeted separation of complex reaction mixtures. The increased plate counts associated with HPLC columns further facilitate efficient separation, especially when dealing with high load volumes necessary for preparative-scale purifications. This not only ensures the production of higher purity products but also expedites the purification process. In the specific context of our probes, incorporating oligo(ethylene glycol) moieties with organelle-specific functional groups, preparative reverse phase HPLC is particularly advantageous. It enables the use of water-rich mobile phases, overcoming the limitations associated with silica gel normal phase column chromatography, which utilizes organic solvents that could excessively solubilize polar products, resulting in broad peaks and co-elutions. With preparative HPLC, we gain precise control over solvent strength, yielding tight, concentrated bands that can be efficiently collected at the preparative scale. Rationale: High-performance liquid chromatography is an essential technique in modern analytical chemistry, allowing for the separation, identification, and purification of chemical compounds. The preparative column with a refractive index detector is particularly valuable for our research, and the chosen system offers the following advantages: 1. High-Resolution Separation: The HPLC preparative column will provide high-resolution separation of complex mixtures, allowing us to isolate target compounds with greater precision. 2. Purification Capability: The preparative column we are hoping to obtain is designed for 1 g of material, making it suitable for the purification of compounds at preparative scale, a critical aspect of our research objectives. 3. Refractive Index Detection: This will enable the detection and quantification of compounds based on differences in their refractive indices. This will be useful for the separation of all molecules as it is non-selective and responds to everything coming off a column. Unlike UV detection, it does not rely on chromophores in the mixtures. Additionally some compounds have weak UV absorptions. In essence it provides universal detection of compounds. 4. Reverse Phase: As the system is reverse phase, water or a water-based solvent can be used in the mobile phase. This has many advantages over normal phase HPLC including lower costs compared to other HPLC methods, less toxicity, accurate results, reduced solvent evaporation (as polar solvents utilized), can change pH to affect separation, elimination of skewed analyte retention times, and increased accuracy of gradient separations. 5. Non-toxic solvent use: Finally, another significant advantage is the ability to analyze samples containing polar (hydrophilic), non-polar (hydrophobic), ionic, and ionizable compounds, due to the use of a hydrophobic stationary phase. Benefits to NIH: The acquisition of the proposed HPLC preparative column with a UV detector will not only advance our research capabilities but also align with the NIH's mission to support groundbreaking scientific discoveries. The resulting research outcomes will contribute to the understanding of ratiometric fluorescent probes, with implications for the development of new diagnostic tools, therapeutic agents, or other applications that align with the NIH's broader goals. Conclusion: The acquisition of a preparative HPLC system is motivated by its unparalleled resolving power, flexible solvent options, and scalability in purifications. This strategic shift addresses the challenges inherent in the composition of our probes, ensuring efficient and high-quality purification tailored for their intended biomedical imaging applications. The chemistry department will maintain and preserve this instrument beyond the 3-year timeline of the NIH proposal GM152969. A confirmation letter from the department chair Dr. Athar Ata is attached.